Integrating Multi-Modal Data for Predicting Post-Surgical Pain Outcomes: Towards Personalized Pain Management

PROJECT SUMMARY/ABSTRACT
Post-surgical pain (P-SP) affects up to 30% of U.S. patients and up to 50% for high-risk surgeries like thoracotomies and
amputations, with global incidence ranging from 5% to 85%. P-SP imposes an economic burden of $560-$635 billion
annually, including direct medical expenses and indirect costs like lost productivity and disability claims. Current
treatment relies on generalized pain management protocols, leading to poor outcomes, higher chronic pain risk, and
increased opioid use. A more personalized approach is urgently needed to improve treatment effectiveness by accounting
for individual pain sensitivity and psychological factors.
To elucidate the neural and psychological mechanisms underlying P-SP and to facilitate early identification of patients at
risk for chronic pain, enabling more targeted interventions, the proposed secondary analysis project will develop an
interpretable and predictive model for P-SP outcomes by 1) identifying the most predictive features of P-SP outcomes
using multi-modal data (functional neuroimaging, psychological, behavioral, and medical history); 2) applying Shapley
value analysis to the output of supervised machine learning models to interpret the contributions of each feature to the
predictions, providing clinicians with patient-specific insights to improve pain management and support personalized
treatment planning; 3) developing a time-series model to predict P-SP outcomes and 4) applying Shapley value analysis to
identify key temporal patterns that influence these predictions.
The expected outcomes of this highly innovative project include the identification of reliable biomarkers for P-SP, which
will serve as a foundation for developing individualized pain management strategies. The findings have the potential to
transform post-surgical care by improving the early detection of P-SP, optimizing treatment protocols, and reducing
opioid use. Ultimately, this project aligns with the broader movement toward personalized medicine and precision
healthcare, offering a comprehensive solution for enhancing patient outcomes and alleviating the long-term burden of
chronic pain on the healthcare system. This directly supports one of the primary missions of the National Institute of
Biomedical Imaging and Bioengineering (NIBIB).
2

Public health relevance
PROJECT NARRATIVE Current treatment for post-surgical pain relies on generalized pain management protocols despite substantial individual variability in pain sensitivity and psychological factors, resulting in suboptimal outcomes and an increased risk of chronic pain development, which negatively impacts quality of life and impairs physical and emotional functioning. By identifying critical predictors of post-surgical pain and quantifying their contributions to individual patient risk, this project will enable the development of personalized pain management strategies, directly contrasting the conventional one-size-fits-all approach. This project aligns with the broader movement toward personalized medicine in healthcare, offering a precision- based solution that responds to the unique needs of each patient.